Lab-supported Antimicrobial Stewardship at the Cornell University Hospital for Animals

Project Summary/Abstract Large veterinary teaching hospitals are in a unique position to promote the judicious use of antimicrobials, particularly for companion animals. Cats and dogs are a growing concern for harboring multi-drug resistant organisms. Given the current lack of regulations on antimicrobial usage in companion animals, it is imperative to teach DVM students how to prescribe treatments appropriately using data from reliable diagnostics. This project will support the development of a formal lab-supported stewardship plan at the highly ranked Cornell College of Veterinary Medicine in line with the FDA CVM 5 year action plan for supporting antimicrobial stewardship in veterinary settings

Public health relevance
Project Narrative In support of the FDA CVM five-year action plan for supporting antimicrobial stewardship in veterinary settings, faculty at the Cornell College of Veterinary Medicine have actively supported the technological capability and capacity of Vet-LIRN laboratories to perform real-time antimicrobial resistance surveillance in a consistent and reliable manner. We now propose to initiate a formal lab-supported antibiotic stewardship plan in one of the top veterinary teaching hospitals in the nation in order to support teaching the next generation of veterinarians how to use antibiotics judiciously.